Type I interferon responses of bone cells to Staphylococcus aureus: A pilot study

PROJECT SUMMARY
Bone disorders such as osteomyelitis that result from bacterial infection are associated
with severe inflammation and progressive bone loss. Staphylococcus aureus is the most
common causative agent of osteomyelitis and the incidence and severity of
staphylococcal osteomyelitis appears to be increasing despite improvements in
prophylaxis and diagnosis. Dysregulation of osteoclast formation and activity results in
bone destruction and/or abnormal bone remodeling at sites of infection, and osteoblasts
play an essential role in the regulation of these bone-resorbing cells. In addition,
bacterially infected osteoblasts and osteoclasts are capable of producing an array of
immune mediators that could promote the recruitment and activation of inflammatory
leukocytes in bone tissue. While type I interferons, such as IFN-a and IFN-b, are best
known for their antiviral effects, it is becoming increasingly apparent that they can
impact susceptibility to bacterial pathogens including S. aureus. Furthermore, IFN-a and
IFN-b have been shown to affect bone homeostasis and are potent inhibitors of
osteoclastogenesis. We have intriguing preliminary data indicating that osteoblasts
express IFN-b, select IFN-stimulated genes, and key intracellular mediators of interferon
effects, in response to S. aureus infection. In this R03 pilot project, we will begin to test
the hypothesis that S. aureus infected bone cells are a significant source of type I
interferons and that such production serves to limit the intracellular bacterial burden and/
or pro-osteoclastogenic responses associated with conditions such as osteomyelitis. We
will characterize the type I interferon responses of isolated bone cells to S. aureus
infection and perform an initial determination of the effects of IFN-a and IFN-b on
bacterial burden and bone cell formation and function in S. aureus-infected osteoblasts
and osteoclasts. These studies will provide critical preliminary data for future studies to
fully define the role played by type I interferons in such infections for which R01
mechanism support will be sought.

Public health relevance
PROJECT NARRATIVE Bone disorders resulting from bacterial infection are associated with severe inflammation and bone loss, but the mechanisms regulating such damage are poorly understood. While type I interferons are increasingly recognized to impact host susceptibility to bacterial pathogens and have been shown to affect bone homeostasis, their role in staphylococcal bone infections has not been examined. In this pilot study, we will begin to determine whether type I interferons serve a protective role in bone infections by limiting the ability of bacteria to survive in local cells and/or by reducing the number and activity of bone resorbing cells.